COMPUTER SIMULATIONS OF MOLECULAR PROPELLERS

The aim of our project is to investigate the behavior of some propeller shaped rotable groups mounted on a molecular grid assembled of connector-like subsystems. Molecular dynamics simulations are used to study these systems. It appears that these molecular propellers or turbines do rotate in rotating electric field and in the flow of rare gas. CGL molecular graphics is used to visualize the structures and their motion.